Somatic mutations in autism spectrum disorder

PROJECT SUMMARY / ABSTRACT
This NIH K08 proposal describes a four-year career development training program in autism spectrum
disorder (ASD) genomics research. With this research program, Dr. Mo will develop expertise in human
genetics, analysis of next-generation sequencing data, and interpretation of somatic variants in non-neoplastic
tissue. These skills complement Dr. Mo’s prior research and clinical training and ideally position her to
transition to an independent investigator position studying somatic mutations in ASD.
Dr. Mo’s mentor for this proposal is Dr. Christopher A. Walsh, a Professor of Neurology at Harvard
Medical School, an HHMI Investigator at Boston Children’s Hospital, and a leader in the genetics of human
neurological diseases. With over 25 years of mentorship experience, Dr. Walsh has an established track record
of mentoring trainees to successful academic careers in biomedical research. Dr. Mo will be supported by a
scientific advisory team and collaborators with complementary expertise in autism genetics, computational
genomics, genotype-phenotype correlations of somatic mutations, and career mentorship. The institutional
resources available at Boston Children’s Hospital, which is affiliated with Harvard Medical School, are world-
class and provide an ideal environment to foster the development of a physician-scientist career.
The primary scientific objective of the proposed research plan is to study the role of somatic (post-
zygotic) variants in ASD. Dr. Mo’s central hypothesis is that somatic variants contribute to ASD risk. Dr. Mo
provides pilot data indicating that somatic single nucleotide variants (sSNVs) are increased in gene exons in
ASD probands compared to controls, particularly in highly constrained genes with loss-of-function intolerance.
Furthermore, Dr. Mo shows that sSNVs in non-coding gene regulatory regions can be efficiently detected using
ATAC-seq, which allows the detection of non-coding sSNVs in larger sample sizes than previously possible
using whole genome sequencing.
To achieve the research objective, a combination of whole exome sequencing, ATAC-seq, whole
genome sequencing, amplicon sequencing, and computational analysis will be used. These strategies will
systemically examine two independent, but related, aims: (1) the burden of sSNVs in functionally-relevant
genes in ASD compared to neurotypical individuals; and (2) the distribution of sSNVs in non-coding gene
regulatory regions in postmortem human brain neurons from ASD and neurotypical individuals. Findings from
this study may improve our understanding of the genetic architecture and mechanisms of ASD as well as the
genetic diagnosis of ASD in clinical practice.

Public health relevance
PROJECT NARRATIVE Autism spectrum disorder (ASD) is a neurodevelopmental disorder that affects 1 in 36 children in the United States. Somatic variants, variants that arise after fertilization, have been implicated in ASD risk, but the types of variants that are enriched in ASD probands as well as the potential contribution of somatic variants in non- coding gene regulatory regions are largely unknown. This proposal will apply innovative approaches to test the hypothesis that somatic variants in both gene coding and gene regulatory regions contribute to ASD risk and can reveal new genes and mechanisms involved in ASD.